Improving the Assessment and Treatment of Chronic Pain in Veterans with Serious Mental Illness

Anticipated Impacts on Veteran’s Healthcare: Chronic pain is a critical obstacle to the rehabilitation and
recovery of Veterans with serious mental illness (SMI; schizophrenia spectrum and bipolar disorders). The
Veteran Health Administration (VHA) has made treatment of chronic pain, especially nonpharmacological
approaches, a high priority and initiated a nationwide dissemination of Cognitive Behavioral Therapy for Chronic
Pain (CBT-CP) – an evidence-based psychotherapy – across the VHA system. However, CBT-CP has not been
scientifically tested in SMI populations and is largely not provided to Veterans with chronic pain and co-occurring
SMI, a group with some of the highest rates of chronic pain and associated negative functional outcomes. This
study will: 1) test the feasibility and acceptability of CBT-CP for improving pain-related functional outcomes in
Veterans with SMI; 2) examine the feasibility of ecological momentary assessment (EMA) to capture real-world
experiences of and relationships among pain, mental health symptoms; and 3) evaluate Veteran experiences
with CBT-CP to inform whether CBT-CP requires tailoring to optimize its use with Veterans with SMI and co-
occurring chronic musculoskeletal pain.
Project Background: Chronic pain is one of the most common physical health diagnoses among individuals
with SMI.1-3 Individuals with SMI and chronic pain report worse mental and physical health functioning relative to
people with other mental or physical health conditions. 4-8 Despite knowing about high rates of chronic pain
among individuals with SMI; little research has been conducted to further understand the complex relation
between pain and psychiatric symptoms and consider the usefulness or appropriateness of current treatment
approaches. What is known is problematic; Veterans with SMI are largely not provided options for
nonpharmacological pain management strategies, including CBT-CP, and are more likely to be prescribed pain
medications that pose unique risks to this population. 9-13
Project Objectives: The proposed CDA-2 research will address research and clinical gaps by better assessing
relations among chronic pain, psychiatric symptoms, and related functional impairment; and testing the feasibility
and acceptability of CBT-CP in Veterans with SMI. The first step of this research will focus on completing a small
randomized controlled trial of CBT-CP to examine feasibility and acceptability and explore changes to functioning
and quality life in 45 Veterans randomized to CBT-CP (n=30) relative to a Health & Wellness intervention (n=15).
We will assess rates of recruitment, initial intervention engagement, and session attendance (feasibility); assess
Veteran satisfaction with CBT-CP (acceptability); and preliminarily explore response to CBT-CP. The second step
will use EMA to collect real-time data (three times daily for one week) on Veterans’ pain, SMI symptoms, and their
impact on functioning using an automated telephone survey. Data will be used to better understand the complex
relationships between these variables. The final step of this research will involve conducting a process evaluation
to consider ways to optimize CBT-CP for future clinical trials to improve functional recovery for Veterans with
SMI and chronic pain. This evaluation will synthesize information from: 1) CBT-CP interventionist notes; 2) EMA
data; and 3) qualitative interviews with a subset of Veterans in the CBT- CP condition (n=15) to learn about their
experiences with CBT-CP, including barriers and facilitators to treatment engagement.
Project Methods: This project will include: 1) completing a randomized control trial (RCT) with 45 Veteran
participants, monitoring fidelity, feasibility, and acceptability; 2) developing and implementing phone-based EMA
to assess temporal relationships among chronic pain, mental health symptoms, and related functioning; and 3)
studying Veterans’ experiences of CBT-CP through qualitative interviews. We will measure functional outcomes
during the EMA and at RCT baseline, post-treatment and 3-month follow-up through self-report questionnaires.

Public health relevance
Chronic pain has a highly negative impact on Veterans, especially those with serious mental illness (SMI). Chronic pain leads to poorer mental health and physical functioning, and represents a critical obstacle to rehabilitation and recovery. Despite known high prevalence rates of chronic pain in SMI populations, there is little research to: a) evaluate nonpharmacological pain management strategies in this population, and b) examine directional relations between chronic pain and SMI symptoms. This study aims to address research and clinical gaps by: a) testing the feasibility and acceptability of Cognitive Behavioral Therapy for Chronic Pain (CBT-CP) - a VA evidence-based psychotherapy for chronic pain in Veterans with SMI, and b) better assessing the complex relation between chronic pain and psychiatric symptoms and their impact on functioning. Results from this study will inform us as to whether CBT-CP is feasible to implement, acceptable to Veterans with SMI, and worth examining in its standard or in an optimized form in a larger clinical trial.